Preliminary imaging studies evaluating the vesicular acetylcholine transporter as a treatment target in major depressive disorder

The cholinergic hypothesis of major depressive disorder (MDD) is based on extensive evidence that
excess brain acetylcholine (ACh) contributes to both the onset and worsening of MDD. However, the specific
neurobiological cause of this dysregulated ACh has not been established in humans in vivo. Based on rodent
data and our preliminary data in humans, one potential mechanism for increased ACh is through the vesicular
ACh transporter (VAChT). For the first time we can visualize and quantify VAChT using the positron emission
tomography (PET) tracer [18F]VAT. We have exciting preliminary data in humans without a diagnosis of MDD
but with a range of depressed mood showing that hippocampal levels of VAChT are inversely correlated with
depression severity. Furthermore, published literature demonstrate (1) decreased VAChT levels (which were
associated with higher depression in our data) were associated with increased ACh levels and (2) increased
ACh in individuals with depression, implying that low VAChT levels may underlie the increased ACh in MDD.
VAChT is therefore a highly compelling candidate for driving cholinergic dysregulation and represents a
completely novel target for treating depression. Thus, we propose a high-risk high-reward mechanistic R21 to
validate this hypothesis and provide initial proof of concept to support larger investigations of the cholinergic
system for potential therapeutic developments in MDD. To achieve this, we propose the following aims: Aim 1.
Assess the role of VAChT in the pathophysiology of MDD by fully quantitative PET imaging using
[18F]VAT. We hypothesize that lower VAChT underlies cholinergic alterations (higher acetylcholine) in MDD
based on animal models of depression exhibiting lower 40% VAChT and our preliminary data indicating
VAChT density is inversely correlated with depression severity. We hypothesize that VAChT density is lower in
7 individuals with MDD compared to 7 healthy volunteers without MDD. Aim 2. Demonstrate that acute
nicotine challenge increases VAChT in those with MDD. Although its mechanism has not been fully
elucidated, transdermal nicotine has been demonstrated to be an effective rapid-onset antidepressant in
humans. And in rodents it was demonstrated to increase mRNA expression of VAChT by 54%. Depressed
individuals from Aim 1 will be treated with nicotine. Based on animal models, we hypothesize that the 7-day
nicotine challenge will increase hippocampal VAChT in 7 individuals suffering from MDD. Our proposed high-
risk high-reward mechanistic R21 would be the first study to assess the role of VAChT in MDD
pathophysiology in humans, determine how VAChT is regulated by nicotine, advance our understanding of the
pathophysiology of MDD, stimulate development of novel cholinergic specific therapeutics, and provide proof of
concept to support future larger studies. Our expected outcomes and positive impact at the end of our
mechanistic study are to have demonstrated a first assessment of nicotine’s effect on VAChT in humans,
involved in its antidepressant effects, and to provide insight into the cholinergic contribution to depression.

Public health relevance
The results of this mechanistic study will provide first evidence for a role of vesicular acetylcholine transporter in the pathophysiology of depression and as the mechanism of action of a novel cholinergic intervention. Our findings will thus provide the first in vivo human support of the cholinergic hypothesis of depression, and the proof of concept to support a larger investigation of this novel biological avenue for treatment.